PULSATILE VS CONTINUOUS INFUSION OF LH SIGNAL FOR TESTICULAR STEROIDEOGENOSIS

This project seeks to evaluate the hypothesis that the pulsatile nature of the endogenous LH signal (i.e. the episodic release of LH under physiological conditions) has a major influence on testicular Leydig cell production of sex steroid hormones and that this influence is age dependent. Similar studies will also be performed in women of reproductive age.